Designing for Dissemination and Implementation Training Hub

The goal of the Designing for Dissemination and Implementation (D4D&I) Training Hub program is to train Veterans Health Administration (VA) providers, researchers, and operational leaders/staff in the D4D&I implementation strategy. Implementation strategies are designed to translate research into practice to improve patient care. This training will increase the knowledge and skills of VA practitioners and researchers who are ready to disseminate and implement care coordination practices across the VA. Our multifaceted D4D&I strategy combines discrete methods that consider the culture, climate, and work environment (i.e. context) of implementation sites. This will increase the impact, effectiveness, adoption, and maintenance of care coordination programs across clinical settings and patient populations and throughout the continuum of care. The four discrete methods of the D4D&I strategy are: 1) Pre-implementation assessment for proactive planning and assessment of multilevel context using the Practical, Robust Implementation and Sustainability Model (PRISM) to ensure program success and sustainability, 2) Multi-level stakeholder engagement to learn what is important to end-users and garner program buy-in, 3) Implementation and adaptations guided by the pre-implementation assessment and stakeholders while retaining fidelity to care coordination program core components, and 4) Program evaluation using RE-AIM (Reach Effectiveness Adoption Implementation Maintenance) to define program outcomes. The D4D&I Training Hub program will address the following aims: 1) Train participants to use the four discrete methods of the D4D&I strategy; 2) Implement a virtual learning collaborative (VLC) to facilitate peer-to-peer learning by providing participants with a forum for sharing experiences; and 3) Evaluate the D4D&I Training Hub implementation strategy using the RE-AIM Framework. Our evaluation will encompass participant learning and satisfaction with the training and professional growth with the VLC, cost of implementing the training hub, and downstream program outcomes and products. The D4D&I Training Hub uses evidence-based experiential and e-learning educational strategies for adult learning. Each training cohort will participate in a 24 week program. Training will occur through Canvas, an e-learning platform during the first 13 weeks. We selected an e-learning format because of its low cost and potential high-impact. Use of an e- learning platform increases accessibility, scale, and spread across the VA. The training content will be delivered in six, 2-hour training weeks over a 13-week period (12 weeks of training with the 13th week being a capstone presentation) with didactic alternating with VLC meetings. The didactic sessions will cover the D4D&I strategy. Participants will learn how to conduct implementation science-guided assessments, engage stakeholders, adapt their care coordination program based on data and feedback, and care coordination program evaluation. Each training week includes educational resources, an interactive didactic curriculum, and instructions for site work. The VLC meetings will be used to draw reflections from participants about the didactic content, facilitate storytelling of how the information has been applied, support peer-to-peer mentoring, allow for assessment of intervention fidelity, and opportunities to reinforce content if necessary. The VLC meetings will occur bi-weekly for the first 12 weeks since the 13th week is a capstone presentation, and then monthly for the following three months. Participants will meet with Faculty Co-Mentors who will be a resource throughout the 24-week program. Faculty Co-Mentors and participants will establish short- and long-term goals and work together to ensure goal attainment.

Public health relevance
The goal of the Designing for Dissemination and Implementation (D4D&I) Training Hub is to train Veterans Health Administration (VA) researchers, practitioners and operational leaders/staff in the D4D&I implementation strategy. The D4D&I strategy targets program adoption, implementation, sustainment, and scale-up and spread. The four discrete methods of the D4D&I strategy are: 1) Pre-implementation assessment for planning and assessment of multilevel context using the Practical, Robust Implementation and Sustainability Model (PRISM) to ensure program success and sustainability, 2) Multi-level stakeholder engagement to learn what is important to end-users and garner program buy-in, 3) Implementation and adaptations guided by the pre-implementation assessment and stakeholders while retaining fidelity to care coordination program core components, and 4) Program evaluation using RE-AIM (Reach Effectiveness Adoption Implementation Maintenance) to define program outcomes.